Mitochondrial stress responses in neurodegeneration

Neurodegeneration is an increasing and unmitigated disease burden in our aging population. These disorders can dim our senses and limit our free movement in the world. A major contributor to these disorders is failure of the energy producing part of the cell called the mitochondria. Damaged mitochondria accumulate in long-lived cells such as neurons and muscle cells and are associated with the common degenerative disorders of our motor system. These include Parkinson's disease, ALS, and mitochondrial myopathy. To understand these disorders our group focuses on families that have mutations in single genes that disrupt mitochondria to cause Parkinson's disease, ALS, and mitochondrial myopathy. The specific genes we have focused on include PINK1, Parkin, and CHCHD2, which cause Parkinson's disease, and CHCHD10 which causes ALS and mitochondrial myopathy. We study these gene in cells and other model systems to understand how mitochondrial failure can lead to neurodegeneration. At the same time, we use these model systems to understand how the cell detects and responds to mitochondrial failure. Harnessing these responses is a promising therapeutic approach for common neurodegenerative disorders.

We have been pursuing this goal through three complementary aims that draw on strengths of the intramural program and my perspective as a cell biologist and neurologist:

SPECIFIC AIM 1: To determine mitochondrial stress responses in and develop therapies for CHCHD2 and CHCHD10 related neurodegeneration, including ALS and mitochondrial myopathy (60% Effort). Mutations in the CHCHD2 and CHCHD10 paralogs share a pathogenetic mechanism of protein misfolding within the part of the mitochondria that is most important for energy production, called the cristae. In knock-in (KI) models and patient cell lines (including iPSCs), we are determining the normal function of CHCHD2 and CHCHD10 and the pathogenesis of these disorders. Additionally, in a collaboration Carlos Rinaldi at Oxford we are developing allele specific antisense oligonucleotide (ASO) treatments for ALS and other forms of neurodegeneration due to mutations in CHCHD10. This year we extended our translational efforts to identify a CRISPR-Cas9 gene therapy approach, which we will be testing in model systems. We have been evaluating a family with ALS due to a mutation in CHCHD10 within the clinical center in collaboration with Dr. Justin Kwan and Dr. Bryan Traynor. This work is currently underway and we anticipate will be published in the next period. Our work for this aim has additionally included collaborating on a project to understand a form of motor neuron disease called spinal muscular atrophy that is caused by a specific mutation in CHCHD10 p.G66V. This work was published during the report period in Acta Neuropathologica Communciations. Additionally, our group contributed to a collaborative paper on biomarkers in ALS that was published in Nature Medicine.

Finally, we have identified a protective mitochondrial stress response against mutant CHCHD10 protein misfolding, which is mediated by the stress-induced peptidase OMA1 and the protein DELE1. This response includes activation of the ISR through cleavage of DELE1 by OMA1, but also inhibits mitochondrial fusion through cleavage of OPA1. We expanded this investigation to mitochondrial myopathies more generally to determine how muscle senses and adapts to mitochondrial dysfunction is not well understood. Using diverse models of mitochondrial myopathy, we showed that the signal for mitochondrial dysfunction originates within mitochondria. The mitochondrial proteins OMA1 and DELE1 sensed disruption of the inner mitochondrial membrane and, in response, activated the mitochondrial integrated stress response (mt-ISR) to increase the building blocks for protein synthesis. In the absence of the mt-ISR, protein synthesis in muscle was dysregulated causing protein misfolding, growth retardation, and decreased survival. The mt-ISR was similar following disruptions in mtDNA maintenance (Tfam knockout) and mitochondrial protein misfolding (CHCHD10 G58R and S59L knockin) but heterogenous among mitochondria-rich tissues, with broad gene expression changes observed in heart and skeletal muscle and limited changes observed in liver and brown adipose tissue. Taken together, these findings identified that the DELE1 mt-ISR mediates a similar response to diverse forms of mitochondrial stress and is critical for maintaining growth and survival in early-onset mitochondrial myopathy. This work was published during this annual report period in The EMBO Journal.

SPECIFIC AIM 2: To identify modulators of and pathogenic mutations in the PINK1-Parkin pathway (25% Effort). Mutations in PINK1 and Parkin are the most common genetic causes of early onset Parkinson's disease. Togethe Through comprehensive analysis of PRKN in NIH PD clinic patients and public datasets, we have found that PRKN missense variants are common, but most are not functionally characterized. We have developed a novel FACS based reporter of Parkin activity, which we are using to determine which PRKN variants are benign, and which are loss of function in a pooled format. We are additionally using this reporter to identify modulators of the PINK1-Parkin pathway in genome-wide screens. Finally, we are establishing the molecular diagnosis of patients with early onset and/or familial PD at the NIH and U Penn.

SPECIFIC AIM 3: To develop novel methods to measure protein turnover in models of neurodegeneration (15% Effort). Using dynamic proteomics and nanoscale metabolic imaging, we are developing novel methods to assess mitophagy and other mitochondrial stress responses in models of neurodegenerative disease and myopathy. These methods will complement efforts in other aims, in addition to their broader applications.